Two-photon laser-scanning microscope for interdisciplinary collaborations at Weill Cornell

Project Summary
This is a proposal by investigators in neurophysiology, neurodevelopment, immunology,
microbiology, and neurodegeneration for a Shared Instrumentation Grant to purchase an
Olympus Fluoview Multiphoton Excitation Resonance Scanning (FVMPE-RS) Microscope
equipped with two Spectra-Physics Ti:Sapphire Ultrafast Lasers. The Olympus FVMPE-RS is an
innovative, state-of-the-art two-photon (2P) laser-scanning microscope that allows for
simultaneous fluorophore excitation and imaging at two different wavelengths and is specially
designed for in vivo imaging applications in neuroscience. By permitting the concurrent
excitation of two genetically encoded calcium sensors with discernible emission spectra
expressed independently in different neuronal subtypes, it is possible to assess the activation
and interaction of different neuronal networks in behaving animals. The specially designed
gantry system allows for 355 mm of clearance between the microscope objective and the
baseplate, enabling users to install customized behavioral equipment for especially complex
behavioral assays to be performed concurrently with in vivo imaging. The same equipment will
also allow for simultaneous 2P imaging and 2P optogenetic stimulation, enabling the
investigators not only to record from neuronal networks but also to manipulate their activity in
real time, with single-cell precision. The requested instrument would enable Weill Cornell
investigators to conduct multidisciplinary experiments spanning neurophysiology, developmental
neurobiology, immunology, and microbiology.

Public health relevance
Project Narrative This is a Shared Instrumentation Grant proposal requesting funds to purchase a state-of-the-art multiphoton laser scanning microscope. The requested instrument would enable a multidisciplinary team of investigators at Weill Cornell Medicine to conduct a variety of cutting-edge experiments spanning neurophysiology, developmental neurobiology, immunology, and microbiology.